JAK Signaling as a Mechanism of Inflammation-related Reward and Motor Circuit Deficits in Depression

Project Summary
This project will test the hypothesis that signaling through Janus kinase (JAK) and signal transducer and activator
of transcription (STAT) pathways is a key mechanism mediating the effects of inflammation on corticostriatal
circuits related to motivation and motor activity as well as symptoms of anhedonia and psychomotor slowing in
patients with major depression (MD). The role of JAK/STAT pathways will be examined using a FDA-approved
JAK inhibitor, baricitinib, and an innovative biomarker-driven, brain-targeted approach. MD is a disabling
disorder, with over 1/3 of MD patients failing to respond to conventional antidepressant therapies. Thus, the
elucidation of novel pathways to pathology and related treatment targets is imperative. One pathophysiologic
pathway thought to contribute to symptoms of depression and particularly anhedonia is inflammation. A
significant proportion of patients with MD exhibit elevated biomarkers of inflammation in the peripheral blood and
central nervous system (CNS), e.g., C-reactive protein (CRP) and inflammatory cytokines such as interleukin
(IL)-6 and tumor necrosis factor, which are in turn associated with antidepressant nonresponse. A rich literature
demonstrates that inflammation affects dopamine (DA) in key brain circuits involving the striatum and prefrontal
cortex that are critical for motivation and motor activity. Our group has established that MD patients with higher
endogenous inflammation (as indexed by peripheral blood CRP and inflammatory cytokines) have low functional
connectivity (FC) within DA-rich corticostriatal reward and motor circuits in association with anhedonia and
psychomotor slowing, which is improved by drugs that increase DA. Interestingly, our published and preliminary
data indicate that JAK/STAT signaling is a key transcriptional pathway that is reliably associated with
inflammation’s effects on DA and motivation and motor circuits and related symptoms. Thus, small molecule JAK
inhibitors like baricitinib may be an optimal strategy to target these immune pathways in MD, especially given
known advantages of these agents over anti-cytokine antibodies including notably CNS penetrance. Indeed,
baricitinib was found to reverse the inhibitory effects of IL-6 on DA neurons derived from human induced
pluripotent stem cells through inhibition of JAK/STAT3 signaling, while also blocking inflammation and reducing
depressive-like behavior in a laboratory animal model. These data are intriguing given evidence from laboratory
animals that IL-6 has direct access to the DA-rich ventral striatum through breaches in the blood brain barrier in
the context of stress. Of note, STAT3 was recently identified as a top upstream mediator of the molecular
pathology of MD. Given the wealth of clinical and translational evidence regarding the role of JAK/STAT
pathways in the pathophysiology of MD, this project will examine whether JAK inhibition with baricitinib can
improve inflammation-related deficits in reward and motor circuits (Aim 1) in association with improved
motivation and motor function (Aim 2) in MD patients enriched for high CRP, while exploring additional CNS and
peripheral immune pathways (Aim 3) that may inform avenues for future work.

Public health relevance
Project Narrative Mounting evidence suggests that signaling through Janus kinase (JAK) and signal transducer and activator of transcription (STAT) pathways mediate the effects of inflammation on dopamine and neurocircuitry related to motivation and motor activity, as well as symptoms of anhedonia and psychomotor slowing. This proposal will use the FDA-approved JAK inhibitor baricitinib to determine the role of JAK/STAT pathways in inflammation- related alterations in motivation and motor circuits and related behaviors in patients with major depression and increased inflammation. Findings will provide important data on the immunologic mechanisms by which inflammation affects the brain, while informing future work on novel treatments for this disabling disorder.